Multi-level assessment and rehabilitation of combat mild traumatic brain injury

Combat-related mild traumatic brain injury (mTBI) and co-morbid conditions are prevalent in returning Veterans
with the reported rates ranging from 14- 22%. Chronic sequela of mTBI can be highly debilitating due to
deficits in the cognitive control processes, including attention, executive functions, and memory. In prior
studies, individuals with chronic acquired brain injury who participated in a cognitive training program, Goal-
Oriented Attentional Self-Regulation (GOALS), which targets executive control functions of applied
mindfulness-based attention regulation and goal management, improved cognitive performance in areas of:
complex attention/executive function and memory, complex functional task performance, and daily functioning.
Furthermore, functional MRI (fMRI) results after training indicated significantly enhanced modulation of neural
processing. Preliminary data from recently completed randomized-control GOALS study in 32 Veterans with
chronic TBI also show both short and longer term (up to 2 years) improvements in attention and executive
function, complex real-life tasks, and emotional regulation.
The primary objectives of this study are to investigate the potential short and longer term effects of GOALS
cognitive training program, and to use advanced MRI to investigate changes in brain structure and function in
the circuits that regulate attention, memory, executive function and emotion in Veterans with chronic mTBI.
We postulate that 1) GOALS training will improve neurocognitive function in attention and executive function
domains, complex functional task performance, and emotional regulation in Veterans with chronic mTBI; 2)
improved neurocognitive function will be correlated with macrostructural, microstructural and functional
changes in the corresponding brain networks on high field (3T) and ultra-high field (7T) structural MR imaging,
diffusion tensor imaging (DTI) and resting state fMRI performed pre- and post-training; 3) Changes in both
behavioral function and imaging measures will be maintained at 6 months post-training and be associated with
improvements in activities and participation.
AIM 1: To determine the short and long term effects of GOALS training on neuro-cognitive performance and
neural plasticity of attention and executive control networks in mTBI.
AIM 2: To determine the short and long term effects of GOALS training on complex functional task
performance and daily functioning, and on plasticity in pathways related to memory function, in mTBI.
AIM 3: To determine the short and long term effects of GOALS training on measures of emotional regulation,
and on plasticity of frontolimbic networks related to emotion processing, in mTBI
In a randomized, controlled interventional study design, 36 Veterans with a history of chronic (> 6 month) mTBI
and residual cognitive difficulties will be randomized to participate in 5 weeks of cognitive training (GOALS) or
a treatment as usual (TAU) comparison. At baseline, week 5 (post GOALS), and at 6 months, participants will
undergo a multi-level assessment battery consisting of: 1) neuroimaging with high field (3T) and ultra-high field
(7T) structural MR imaging, diffusion tensor imaging (DTI) and resting state fMRI; 2) neuropsychological
assessment focusing on complex attention and executive function; 3) complex `real life' functional task
performance; and 4) self-report measures of daily functioning and emotional regulation/heath.
When completed, this project will determine whether training core attentional self-regulatory control functions
via personally-relevant activities will be effective in improving quality of life and daily functioning for Veterans
with mTBI. The study design will provide a test of potential benefits on real-life functioning, and also determine
to what extent these benefits are related to actual changes in hypothetically targeted cognitive/behavioral
functions and brain networks corresponding to these functions.

Public health relevance
One of the most pressing concerns within the VA currently is the provision of interventions that address the cognitive as well as emotional problems faced by Veterans with mild TBI and comorbid conditions. When completed, these studies will inform us whether training core attentional self-regulatory control functions via personally-relevant activities will be effective in improving daily life for Veterans with mild TBI and comorbid conditions. The study design will provide a test not only of potential benefits for real life functioning, but also determine to what extent these benefits are related to actual changes in cognitive/behavioral performance and brain networks corresponding to these functions. This project will provide a foundation for future studies to investigate the neural mechanisms that support improvements of cognition and behavior in mTBI.